Targeting isocitrate dehydrogenase mutations by enzyme hyperactivation

PROJECT SUMMARY/ABSTRACT
Mutations in isocitrate dehydrogenase (IDH) enzymes are hallmarks of a variety of deadly cancers, including
acute myeloid leukemia (AML), glioma, cholangiocarcinoma, chondrosarcoma, and T cell lymphoma. Mutant
IDH enzymes drive cancer through an unusual mechanism – they produce a metabolite called 2-
hydroxyglutarate (2HG) that poisons gene expression machinery and locks malignant cells in a stem cell-like
state. Drugs that inhibit mutant IDH enzymes induce durable clinical responses in some patients with IDH-
mutant cancers, leading to FDA approvals for AML and cholangiocarcinoma. However, despite near universal
inhibition of 2HG production, over half of patients do not respond to IDH inhibitors. Even for patients who
initially respond to IDH inhibitors, most eventually acquire resistance to the drugs. While the mechanisms of
resistance to IDH inhibitors remain incompletely understood, emerging evidence suggests that acquisition of
specific co-occurring mutations during tumor evolution results in a loss of dependence on 2HG. Therefore, we
need new treatment approaches that target IDH mutations in different ways beyond simple inhibition of
the enzyme. We previously identified an unusual pattern of resistance mutations in the dimer interface of
mitochondrial IDH2 wherein they occur in trans (on the other allele) relative to the 2HG-producing active-site
mutation. Here, we show that in contrast to the in trans mutations that drive drug resistance, forced expression
of a dimer-interface mutation in cis with the active-site mutation resulted in mitochondrial dysfunction and
impaired growth of leukemia cells. Biochemical and structural studies demonstrated that the in cis dimer-
interface mutation enabled IDH2 to aberrantly use NADH as an additional cofactor and dramatically enhanced
production of 2HG. Seeking to exploit the toxicity exerted by the in cis dimer-interface mutation, we performed
a chemical screen and identified small molecules capable of mimicking this aberrant enzymatic activity with
selective toxicity towards IDH2-mutant leukemia cells. Thus, we hypothesize that hyperactivation (rather
than inhibition) of mutant IDH offers an unexpected and effective new strategy to target IDH-mutant
cancers. This hypothesis will be rigorously tested in three Specific Aims. Aim 1 will use enzyme assays and
structural approaches to elucidate the biochemical basis for mutant IDH2 hyperactivation. Aim 2 will employ in
vitro and in vivo cancer models to define the mechanisms of toxicity arising from hyperactivation of mutant
IDH2. Aim 3 will utilize biochemical and functional approaches to determine if the approach of hyperactivation
can applied to cytosolic IDH1 mutations. The proposed studies will reshape our understanding of the
oncogenic properties of 2HG and the biochemistry of neomorphic IDH activation. More fundamentally, this
work will demonstrate the feasibility of an entirely novel hyperactivation approach as a strategy to harness
oncogene-mediated toxicity that could be applied to a wide range of oncogenes and cancer contexts.

Public health relevance
NARRATIVE Drugs that inhibit mutant forms of the metabolic enzyme isocitrate dehydrogenase (IDH) enzymes were recently approved as therapies for some leukemias and solid tumors. However, inhibiting mutant IDH enzymes helps less than half of patients with IDH-mutant cancers, and drug resistance invariably develops. The proposed research investigates the surprising discovery that hyperactivation, rather than inhibition, of mutant IDH enzymes might offer a more effective strategy to treat IDH-mutant cancers.